Administration and Management

Abstract: Administration. A successful enterprise that has many components and is geographically
distributed requires effective communication among the participants and meaningful metrics for progress. The
Administrative Core provides support for and oversight of the components and participants in the Center for
Biomolecular NMR Data Processing and Analysis.!